2023 Sex Differences in Immunity Gordon Research Conference

SUMMARY
Partial support is requested for a new Gordon Research Conference (GRC) on Sex Differences in Immunity.
The inaugural conference will be held April 2-7, 2023 at the Four Points Sheraton in Ventura Beach, California,
The Sex Differences in Immunity GRC is a premier, international
scientific conference focused on advancing the frontiers of science through the presentation of cutting-edge
and unpublished research, prioritizing time for discussion after each talk and fostering informal interactions
among scientists of all career stages. This is the first GRC dedicated to sex differences, and the concentration
on immunity is timely given growing appreciation that biological sex,
near the Los Angeles International Airport.
meaning the differences between males
and females caused by differential sex chromosome complement, reproductive tissues, and concentrations of
sex steroids, impacts the functioning of the immune system. Although sex differences in immune function have
been documented for decades, the COVID-19 pandemic considerably raised awareness about the implications
The conference program includes a diverse range of speakers and
discussion leaders from institutions and organizations worldwide, concentrating on the latest developments in
sex differences in immunity ranging from infectious diseases and cancer to autoimmunity, mucosal immunity,
metabolics, and genomics. The conference is five days long and held in a remote location to increase the
sense of camaraderie and create scientific communities, with lasting collaborations and friendships. In addition
to premier talks, the conference has designated time for poster sessions from individuals of all career stages, a
power hour dedicated to addressing challenges to achieving equity in science among women and all
underrepresented groups, and afternoon free time and communal meals to allow for informal networking
opportunities with leaders in the field.
of sex differences in immunity to viruses.
Underrepresented minority scientists are well represented among
meeting discussion leaders, speakers, and attendees. Through conscious consideration of representation and
inclusion, the Sex Differences in Immunity GRC will foster involvement of underrepresented minority
individuals at all levels. Funds are requested to support registration fees for invited discussion leaders and
speakers, conference and travel support for junior investigators and trainees, expenses related to room rental
and associated technical support, and poster board rentals. The annual meeting program is freely available on
the GRC website.

Public health relevance
NARRATIVE The proposal requests partial support for the inaugural 2023 Sex Differences in Immunity Gordon Research Conferences (GRC) to be held April 2-7, 2023 at the Four Points Sheraton in Ventura Beach, California, which the sense of camaraderie and create scientific communities. The Sex Differences in Immunity GRC is a premier, international scientific conference that will advance the frontiers of science through the presentation of cutting-edge and unpublished research, prioritizing time for discussion after each talk, and fostering informal interactions among diverse scientists of all career stages. We have developed a program that reflects an equitable and inclusive environment, and promotes the research of women and underrepresented groups in biomedical sciences. is a remote location that will foster